Mount Sinai Clinician Scientist Training Program in Emergency Care Research

Emergency medicine lags behind other fields in the scope and depth of its research enterprise due, in part, to a lack of well-trained investigators. To address this, the highly regarded Department of Emergency Medicine in the Icahn School of Medicine at Mount Sinai established the “Mount Sinai Clinician-Scientist Training Program in Emergency Care Research” (ECR) to train clinician-scientists in emergency care research. Having enrolled fifteen outstanding postdoctoral fellows thus far, this multidisciplinary program has expanded to recruit and train doctoral-level applicants from health- related professions in addition to clinicians trained in the specialties involved in ECR: emergency medicine, cardiology, pulmonary, critical care, & trauma surgery. The overall aim of the program is to provide research-minded clinicians and health-related professionals with a strong foundation in the principles of clinical research or health services research and the mentored research experiences necessary to: a) pursue independent careers in ECR; b) function as valuable, contributing members of multidisciplinary research teams; and c) accelerate dissemination of findings and rapidly translate their research into clinical practice.
Led by Drs. Lynne D. Richardson and Alex Manini, both experienced emergency physician-scientists and successful mentors, the program partners with Conduits – the Mount Sinai CTSA, and colleagues in Medicine, Cardiology, Pulmonary Medicine, Critical Care, and Population Health Science & Policy, as well as collaborating research faculty from throughout the institution to offer a well-rounded, collaborative research training experience. Forty faculty members from 10 departments serve as potential research mentors or as translational or methodological advisors. Key program components include superb multidisciplinary mentorship, individual and collaborative research activities, formal didactic instruction, and career and leadership development activities. Each fellow’s Individual Development Plan includes completion of a Master’s degree in Clinical Research or equivalent research degree. New postdoctoral fellows are enrolled each year for 2-3 years of training. This training grant also supports a short-term training program for ten weeks each summer to introduce research-interested predoctoral students to clinical and health services research in the emergency care setting. The program, program leadership, mentors, and fellows are evaluated annually, and the findings are used for program improvement. Three distinguished emergency care research experts from across the nation serve on the External Advisory Board, which meets annually with fellows and program leadership to further enhance the program.

Public health relevance
U.S. Emergency Departments (ED) had approximately 155.4 million visits in 2022, a figure that has been steadily rising for the past twenty years. Twenty-five percent of the U.S. population visits the ED each year, these include many of the sickest individuals in the health care system, presenting with complex disease processes and a high prevalence of adverse events. There is a specific need for emergency care clinicians and related health professionals to be trained as clinical and health services researchers to improve health outcomes and decrease preventable ED visits.